HSR&D Research Career Scientist Award

This Research Career Scientist award will support Dr. Christine W. Hartmann in expanding her scientific
research, mentoring, and service contributions beyond what would be otherwise possible, thereby considerably
increasing her positive impact on the missions of VA and HSR&D. Dr. Hartmann is a senior VA health services
researcher and implementation scientist conducting rigorous, health system-relevant research. She works
closely with VA operational partners and has had tremendous success in rapidly translating research findings
into practice. The portfolio of her work as PI concentrates primarily on improving care for some of VA's most
vulnerable and high-risk Veterans, those living in VA's Community Living Centers (CLCs, i.e., nursing homes).
At an annual cost of almost $4 billion, the CLC system provides vital care for Veterans who frequently contend
with multiple chronic conditions and are often rejected by community nursing homes. Yet CLCs vary greatly in
the quality of care they provide, with poor quality care sometimes making front-page national news, drawing
attention at the highest levels of VA and Congress. Dr. Hartmann's portfolio of work identifies and addresses
these gaps in quality of care. She has made substantial clinical and policy contributions through her two main
research foci: pioneering the measurement and investigation of quality of care and being an exemplar of using
implementation science to improve care outcomes.
Dr. Hartmann's work in CLCs has had enormous impact. One example is from a line of HSR&D studies in
which she developed effective, evidence-based interventions and an implementation strategy to enable CLC
staff to improve their quality of care. Based on the studies' success, the Office of Geriatrics and Extended Care
rolled the resulting interventions out nationally and created a national CLC quality improvement center that Dr.
Hartmann co-directs. This center has $7 million in funding to date and yearly support for over 7 FTEE. Dr.
Hartmann is also spreading these interventions outside VA. She was awarded a 5-year, $7.2 million NIH
pragmatic clinical trial in community nursing home corporations to improve sleep outcomes for nursing home
residents with dementia. QUERI has also funded Dr. Hartmann's implementation strategy as a Training Hub to
enable its use outside the CLC setting. This work has led to meaningful and demonstrable improvements in
CLCs' clinical quality outcomes and changes to national CLC policy and is only one example of the impact of
her studies. In total, Dr. Hartmann has led, as PI, 8 large VA and NIH grants totaling almost $15 million.
Dr. Hartmann contributes significantly at the local and national levels. She participates on VA and NIH grant
review panels, publishes in top journals, and mentors extensively, including VISN 1 and HSR&D CDA
awardees. She was recruited to her current university in part to provide faculty mentoring in grant proposal
development. She is a sought-after speaker on quality improvement research and implementation science. Dr.
Hartmann will use this award's support to achieve the following specific aims. Aim 1: Improve nursing home
quality of care outcomes, including at low performing sites. We know little about how to achieve and
sustain improvement in low performing CLCs. Dr. Hartmann address this gap not only through research but
also through spearheading cross-VA collaboration. Aim 2: Enhancing the spread of implementation
science in long-term care research. Dr. Hartmann will expand her methodologic contributions through
research and publication and will work with existing national groups to meet the field's pressing needs. Aim 3:
Identify and mentor early career scientists in these areas. Dr. Hartmann will maintain her many mentoring
activities and will continue leveraging her own expertise and collaborations to lead HSR&D's national efforts to
recruit and support early career scienists, including those from underrepresented groups.

Public health relevance
Community Living Centers (CLCs) provide care for over 40,000 vulnerable Veterans every year and serve as a safety net setting for many Veterans who cannot find care in non-VA nursing homes. This award will support Dr. Hartmann's research on measuring and improving the quality of CLC care, helping Veterans who live in CLCs have better outcomes. Dr. Hartmann's work to date with CLCs across the nation shows this is possible. CLCs that use techniques she developed have, for example, improved care and risen in their quality rankings. This award will expand this type of research, helping the VA system better provide high-quality Veteran care.